Emergency Medicine Research Training

Project Summary / Abstract
The Emergency Medicine Research Training program will continue to provide postdoctoral scholars with
didactic and mentor-driven experiential training in clinical emergency care research, focusing on topics within
the mission of NHLBI. This program provides a curriculum customized for early career investigators to teach
skills for a research career in the unique setting of emergency care, thus providing training not available in other
training programs. Specific aims are (1) to sustain the administrative structure for the program, (2) to engage
faculty in formal mentoring roles (3) to organize a curriculum that specifically addresses unique aspects of
emergency medicine and acute care research, and (4) to recruit and monitor the initial and long-term success of
high-quality emergency medicine clinical investigators. Scholars will be early career physicians or post-
doctoral scholars who focus on acute illness and injury. Over two or three years, scholars will conduct primary
investigations with input from expert mentors with acute care research careers. A didactic program, including a
thesis, will lead to a master’s or other advanced degree. A short-term experience for medical student or other
predoctoral trainees will continue to recruit high quality individuals from diverse groups into emergency care
research careers.

Public health relevance
Project Narrative: There are unique challenges to conducting research in emergency care, and few training programs directly address these challenges. This program offers interdisciplinary training to provide early-career clinical scientists with didactic and experiential training in clinical emergency care research. We will increase the number of highly qualified physicians and scientists working to improve emergency care for the public.